Developmental Research Project Program

ABSTRACT
The NH-INBRE Developmental Research Projects Program (DRPP) provides student research training, grows
faculty research productivity and independence, and strengthens research and scientific culture at our Partners.
The DRPP accomplishes these overall aims by soliciting, reviewing, and awarding, individual and collaborative
biomedical developmental research and pilot projects to investigators in the Network. Additionally, the DRPP
provides faculty with scientific and career mentorship and training to improve faculty research productivity and
competitiveness for extramural funding opportunities. While the NH-INBRE co-leads have considerable external
research support, the 9 primarily undergraduate (PUI) 4-year college Partners, and the Community College
System of New Hampshire have drastically less research support. DRPP-supported projects that provide project
leaders with supply funds, student salaries and faculty course release have been central for increasing the
research activity and enhancement of the research culture in our Partner Network.
The DRPP will develop and release funding opportunity announcements to NH-INBRE Partner institutions to
solicit biomedical research proposals from faculty members. Project proposals will be evaluated by reviewers
with relevant scientific expertise and scored using NIH criteria. Both scientific merit and the ability of the project
and its Project Leader to provide a solid research experience for undergraduate students participating in the
project are considered in ranking proposals. The DRPP will increase faculty research and mentoring productivity
through scientific mentorship and training. Project leaders will be assigned a mentoring team consisting of an
Academic Mentor from their institution, one or more trained Scientific Mentors, and a member of the NH-INBRE
AC faculty leadership. Mentoring meetings held twice each year will focus on a Research Development Plan
(RDP) that outlines short- and long-term expectations, goals, progress, and outcomes. PLs will have access to
core facilities and scientific training opportunities at the co-Leads, including the COBRE-supported cores, BioMT,
CQB, and CIBBR, for biochemical, high throughput screening, single cell, bulk and spatial sequencing,
microscopy, and flow cytometry and many other scientific approaches. A grant writing workshop series that meets
September through February will personally guide PLs and faculty through submission of a new or revised NIH
R15 grant application. Last, the overall impact of the DRPP will be reviewed annually and discussed in detail
with the EC, SC, and EAC. These reviews and formative evaluations will guide future DRPP improvements.